Administrative Core

Project Summary Administrative Core The Administration Core will oversee all aspects of the Center and coordinate its activities. This includes a plan for information transfer between projects as well as information dissemination to the scientific community and to the public. Core A will be responsible for assuring that milestones are met and in consultation with NIH, will appoint and interact with the External Advisory Board. The training and outreach programs will be administered through Core A. Finally, Core A will oversee standard administrative tasks such as the budget and resource allocations and maintain the Center web site. Dr. Haber will be responsible for the overall direction of the Center. Dr. Greenberg will specifically coordinate the clinical aspects of the Center and lead the outreach program. Dr. Quirk will lead the training program. A steering committee chaired by the Dr. Haber, will include the PIs and Co-PIs of all Projects and Cores. This committee will meet monthly and be responsible for meeting scientific timelines and milestones in a timely manner; interact with the External Advisory Board; Training and outreach; oversee resource allocation and reallocation; oversee the web site, and resource and data sharing components of the Center.